Investigation into the Dictyostelium protein quality control network

7. Project Summary A hallmark of many neurodegenerative diseases is the formation of large protein aggregates, leading to neuronal dysfunction and cell death. Protein aggregation results from the accumulation of misfolded proteins, leading to an imbalance in protein homeostasis. A major question is how do cells recognize and deal with misfolded proteins? Thus, insight into mechanisms responsible for preventing protein aggregation would be beneficial. Serendipitously, we found that the model organism Dictyostelium discoideum normally express proteins with long polyglutamine tracts that cause one class of neurodegenerative diseases. Recently, I showed that Dictyostelium have an extraordinary ability to resist aggregation of a polyglutamine-expanded protein known to aggregate and cause disease. Here, I propose to investigate mechanisms utilized by Dictyostelium to resist polyglutamine aggregation and explore novel aspects of the Dictyostelium protein quality control network.

Public health relevance
8. Project Narrative Protein aggregation is a hallmark of many neurodegenerative diseases. Dictyostelium discoideum is the first organism discovered to be highly resistant to polyglutamine aggregation. Interrogation of Dictyostelium's protein quality pathways responsible for combating protein aggregation is warranted. Data generated will give new insight into protein quality control and potentially lead to identification of novel pathways.